Coupling a multifunctional tag to scalable endogenous tagging technology for improved genome-wide perturbation screens

Project Summary
Characterizing the functions of protein-coding genes is an important goal in the post-genomic era. While
proteins are the ultimate effectors of most cellular functions, including those mis-regulated in disease, we have
an extremely limited understanding of the roles of the majority of proteins in the human proteome. Though
powerful, existing technologies for the high-throughput interrogation of protein-coding genes, including
CRISPR/Cas9-based approaches and RNA interference, require extended periods of time to effect changes in
protein levels, and thus suffer two critical shortcomings. First, they are unable to detect the contribution of growth-
essential genes to any cellular process other than viability, as any cell carrying a perturbation in such a gene
would fail to propagate. Second, compensatory and adaptive effects have ample opportunity to manifest, thus
convoluting screen results by ameliorating the effect of the perturbation, or by generating a novel, unrelated
effect. To address these critical limitations, I propose to develop a new screening technology that will minimize
the time between perturbation and screen readout by inducibly and rapidly degrading endogenous proteins. This
is made possible by a readily scalable endogenous tagging technology that harnesses homology-independent
targeted integration to insert a synthetic exon into the intron of a protein-coding gene at the site of a double
strand break. The synthetic exon will encode a multifunctional ligand-binding protein that depending on the
ligand, will lead to fluorescence or rapid degradation. Pooled libraries of sgRNAs targeting different introns allows
for the creation of custom libraries of cells, where each cell carries this multifunctional tag on a different protein.
The utility of this approach will be established aims 1 and 2 by testing (1) whether cells that have undergone
rapid depletion of growth-essential proteins are maintained in the cell library at the end of the short perturbation
window and (2) whether rapid depletion and CRISPR knockout at the same protein produce different effects on
a well-established phenotype, due to the distorting effects of adaptation events in the knockout. Aim 3 witnesses
the use of a machine learning approach and the data from thousands of attempted tagging events to identify
how the features of a potential tag site dictate the likelihood that a functional protein carrying the multifunctional
tag will be produced. The resulting model will be unleashed on the protein-coding genome to predict high-quality
tag sites for as many protein-coding genes as possible. This will establish an improved screening paradigm that
will allow for the pooled interrogation of the contributions of thousands of proteins to a phenotype of interest, will
thus accelerate the rate at which we come to understand the poorly understood elements of the protein-coding
genome. These efforts will be well supported by the outstanding resources for experimentation and mentorship
at both the University of Pennsylvania and the Children’s Hospital of Philadelphia, and will provide excellent
training in experimental techniques for protein perturbation and characterization, as well computational literacy
in the broadly useful field of machine learning.

Public health relevance
Project Narrative Proteins are the ultimate effectors of most cellular functions in health and disease. Yet, the functions of the majority proteins encoded by the human genome are very poorly understood. A novel high-throughput screening strategy leveraging rapid protein degradation will dramatically accelerate functional characterization of the human proteome.